Metabolic compartmentalization and the regulation of histone propionylation in cancer

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDA) is a deadly cancer for which effective treatments are urgently
needed. Metabolism is extensively reprogrammed in pancreatic cancer to support tumor growth and
progression. The epigenome is sensitive to metabolic alterations since many chromatin modifications depend
on and are regulated by the abundance of key intracellular metabolites that are substrates of epigenetic
enzymes. Disruption of physiological control of the metabolism-epigenome link in cancer cells has been
shown to contribute to tumor growth and progression. Our labs recently identified a novel link between
metabolism and the epigenome, though which branched chain amino acid (BCAA) availability and catabolism
regulates histone lysine propionylation, a mark associated with transcriptional activation. Although BCAA
metabolism is known to be remodeled in PDA, how this impacts chromatin modification and gene expression is
unknown. Furthermore, the metabolic route through which BCAA catabolism supplies propionyl-CoA to the
nucleus for chromatin modification remains unclear. This project will test the hypothesis that propionyl-CoA, the
acyl-donor for histone propionylation, is generated in the nucleus of the cell via a nuclear-localized set of BCAA
catabolic enzymes to regulate site-specific histone propionylation and gene expression contributing to tumor
growth. We will test this hypothesis in two aims, 1) determine the mechanism of nuclear propionyl-CoA
production and 2) Examine the role of BCAA-sensitive histone propionylation in gene regulation and tumor
growth. Elucidation of these processes will provide insight into the mechanistic links between BCAA
metabolism and PDA tumorigenesis, potentially pointing towards new avenues for therapeutic intervention.

Public health relevance
PROJECT NARRATIVE Branched chain amino acid (BCAA) metabolism has recently been shown to regulate the chromatin modification histone lysine propionylation, which is associated with transcriptional activation. BCAA metabolism is reprogrammed in pancreatic ductal adenocarcinoma (PDA), a deadly cancer for which effective treatments are urgently needed. This project will examine the mechanisms through which BCAA metabolism regulates histone lysine propionylation and the role of this pathway in gene regulation and PDA tumor growth.